BODY COMPOSITION, ENERGY EXPENDITURE, AND GROWTH IN WILLIAMS SYNDROME

This study evaluated energy metabolism and body composition in children with Williams syndrome. This autosomal dominant and multi system complex disorder is characterized by growth failure, psychomotor retardation, cardiovascular abnormalities and decreased fat deposition in subcutaneous tissue. This study has concluded, and the data are being analyzed.